Developing a Diverse Next Generation of Leaders in Respiratory Science

PROJECT SUMMARY/ABSTRACT
This proposal is for a new training program that capitalizes on our major local strengths in respiratory physiology
and pulmonary disease. Over time, the field of physiology and pathophysiology has evolved to solve new
problems identified from clinical management of lung airway, interstitial and vascular diseases and to extend the
new discoveries from genetic, genomic, cell and molecular studies to define pathogenic mechanisms and
develop novel therapeutic interventions for lung diseases. We remain focused on the importance of integrated
function and systems biology and thus we use the concepts of physiology as an integrator across respiratory
science studied at multiple levels. With the success of our recent T32 and recruitment efforts, our respiratory
science has broadened to include strength in genetics, (epi)genomics, molecular and cellular biology. While we
view our science as cutting edge, we pride ourselves on the fact that our trainees do not just focus on a single
molecule or gene but rather keep in mind the importance of integrated function and translational research. Our
MPIs include diverse strengths in Pulmonary, Sleep, Genomics, Critical Care, Physiology and Respiratory
Science. The MPIs have mutual respect, complementary expertise, shared vision for scientific progress and a
strong commitment to developing a superb next generation of leaders with rich diversity. To improve the quality
of mentoring, we also removed less effective mentors while adding more R01-funded preceptors and formalizing
the levels of faculty participation based on success in research training, research productivity and current
research funding. We have made both Sleep and Pediatrics as major scientific foci, addressing major national
shortages in these areas. We utilize individual development plans, overseen by the MPIs, Preceptors and senior
advisors, for all of our trainees to empower people with diverse backgrounds. We promote collaboration between
MDs and PhDs, ensure that everyone has experience and competency in inter-, trans- and multi-disciplinary
research, and ensure all of our trainees have a strong foundation in physiological approaches that provides a
clinical context for research problems studied at any level. We promote cohesiveness, team spirit and a unique
identity for our trainees via common activities involving all of our trainees and mentors/preceptors such as
frequent scholarly meetings, career development sessions and quarterly retreats. We are committed to a training
program that includes every phase of academic career development, from ‘cradle to grave’ including developing
junior faculty into independent investigators, and even improving the mentoring skills in our senior faculty. We
also remain committed to diversifying the next generation of respiratory scientists as demonstrated by our long-
term track record and recent recruitments. The lack of a robust pipeline for multidisciplinary researchers who can
apply modern integrative approaches to problems in respiratory science is a crisis which has been further
amplified by the COVID pandemic, but it is a challenge that we are well-qualified and eager to address.

Public health relevance
This proposal is for a new training grant to support a well-established training program that integrates new approaches to make discoveries in lung disease, sleep and critical care. It will support the training of 6 postdoctoral fellows in various types of lung research from basic science to clinical trials. Using physiology as an integrator, individualized mentoring and team science are keys to building on our success at producing leaders in lung research with rich diversity and an ultimate goal of curing lung diseases.